Advancing the implementation of evidence-based strategies for HPV vaccination in safety-net primary care settings

ABSTRACT
There is a critical need to accelerate and sustain the adoption of evidence-based strategies (EBS) for Human
Papillomavirus (HPV) vaccination into safety-net healthcare settings given the suboptimal vaccination rates in
recommended age groups (11-12 years) and persistent disparities in cervical and other HPV-associated cancers
among low-income, racial/ethnic minority populations. Although recommended EBS to improve HPV vaccination
are available, few studies have fully examined the interrelationships among provider, clinic, and health system
levels that enable or inhibit successful integration of EBS for HPV vaccination into routine clinical care. The
proposed four-year sequential mixed-methods study seeks to (1) identify factors at multiple levels that are
associated with implementation of EBS and (2) improve suboptimal HPV vaccination uptake for underserved
adolescents within safety-net settings. Guided by the Practice Change Model, we will engage stakeholders to
systematically and comprehensively examine implementation of actionable EBS for HPV vaccination and apply
findings in a demonstration study of three purposively selected clinic sites within an urban, multi-site federally
qualified health center (FQHC). We then use the Reach, Effectiveness, Adoption, Implementation and
Maintenance (RE-AIM) framework to characterize and understand the implementation of EBS for HPV
vaccination in demonstration clinic sites. The study will: identify how diverse stakeholders view, prioritize, and
adapt actionable provider, clinic and system-level EBS for increasing HPV vaccination through depth interviews
and concept mapping (Aim 1); conduct a demonstration project to implement actionable EBS, identified from
Aim 1, through practice-facilitated approaches in a purposive sample of three clinic sites within a multi-site FQHC
system (Aim 2); and examine practice-based factors associated with implementation of EBS for HPV vaccination
using practice observation, depth interviews, and surveys with physicians, clinic staff, and FQHC leaders (Aim
3). Successful implementation of healthcare setting-based EBS to increase HPV vaccination will require a
systematic understanding of dynamic relationships within and between healthcare settings that influence practice
change. Study findings will identify critical motivators and barriers to translating EBSs for HPV vaccination in
safety-net settings and inform the processes needed to prioritize, adapt, and implement EBS for practice change
within the safety-net context. The study also establishes an opportunity for subsequent examination of
maintenance and scale-up of EBS across practice sites, to be assessed in a longer follow-up period, as well as
a foundation for a larger trial to be conducted with more clinics across varying healthcare settings.

Public health relevance
PROJECT NARRATIVE Human Papillomavirus (HPV) vaccination is an effective primary prevention strategy against HPV infection and associated-cancers, but low uptake of the vaccine indicates research is needed to improve the adoption of evidence-based strategies (EBS) for increasing HPV vaccination rates. This project aims to identify and understand factors at the provider, practice, and health system levels that impact the implementation of recommended EBS within health care settings for underserved populations to inform practice change for HPV vaccine improvement relevant to real-world clinical settings.